Family Spirit Strengths: A home visiting strategy to support parents and caregivers with mental distress and substance misuse

PROJECT SUMMARY/ABSTRACT
Mental health and substance misuse pose some of the greatest risks to the health and wellbeing of American
Indian and Alaska Native (AI/AN) communities and result in intergenerational morbidity and mortality. These
risks are the legacy of historical trauma, ongoing discrimination, and chronic underfunding of mental health and
substance use care, resulting in massive care and treatment gaps. Simultaneously, many AI/AN communities
emphasize a holistic view of wellbeing centered around family and community, and prefer upstream
preventative and family-based interventions with potential to disrupt intergenerational cycles of trauma and
adversity. Our team of Indigenous and allied researchers has worked closely with participating communities to
design and pilot the Family Spirit Strengths (FSS) intervention, designed to provide transdiagnostic skills-
based preventive strategies to mothers and primary caregivers at elevated risk for mental health and
substance use disorders. We propose a Hybrid Type I Effectiveness-Implementation design with the primary
goal of testing FSS effectiveness at reducing symptoms of depression, anxiety, and substance use, among N =
188 primary caregivers across three diverse Tribal settings and contexts. Participants will be randomized to
receive FSS or a beneficial control, which is an evidence-based nutritional support program called Family Spirit
Nurture. Primary outcomes will be measured at 6 months post-enrollment. We will also seek to characterize
heterogeneity in and mechanisms of FSS effects by exploring moderators and mediators, respectively, guided
by both Western and Indigenous theories of action. As part of our Hybrid approach, we will estimate FSS
costs, cost-effectiveness, and budget impact. Finally, we will undertake a process with National stakeholders to
understand barriers to and facilitators of FSS implementation across the country, including co-design of
implementation strategies to support FSS at scale across diverse AI/AN communities. This study is responsive
to Program Announcement PAR-20-238 and focuses on key areas of interest including the testing of evidence-
based practices in community settings (MH-22-170) and expanding perinatal mental health interventions (MH-
21-215, MH-21-270). Our overall objective is to rigorously test a secondary preventative intervention designed
to be embedded in home visiting programs so that we can extend the reach of mental and behavioral health
services in AI/AN communities across the country.

Public health relevance
PROJECT NARRATIVE This project addresses the disproportionate morbidity and mortality associated with mental and behavioral health problems in American Indian and Alaska Native communities. Access to culturally competent and effective behavioral health services is limited in these communities. We aim to address this gap by testing the effectiveness of a transdiagnostic secondary prevention program that can be embedded within home visiting services. Our study is grounded in participatory processes and led by a team of Indigenous and allied researchers.